Administrative

An administrative core will carry out functions that interface with the 3 projects and with the 3 scientific cores. The administrative core will include Dr. Michel Nussenzweig as Core Leader and his Administrative Assistant as well as the Administrative Assistant in the laboratory of Dr. Ralph Steinman. The Administrative Assistants will funcfion to: arrange meefings among invesfigators;prepare protocol submissions and annual renewals to the Institutional Review Boards;arrange contacts and prepare reports;help to prepare, submit and track manuscripts;monitor budgets and manage personnel including immigrafion, sfipends, benefits and housing.